Development of Cobinamide as a Novel Treatment for Aortic Aneurysms of Marfan Syndrome: Phase I Pharmacokinetic Studies

Marfan Syndrome (MFS) is a genetic disorder, with a prevalence of ~ 1 in 5,000 people. Aneurysms in the
ascending aorta are the most serious manifestation of the disease and can lead to sudden death due to
spontaneous rupture. Existing treatments are marginally effective. The aneurysms are due largely to increased
oxidative stress in aortic smooth muscle cells from abnormal production of superoxide anion and nitric oxide.
Cobinamide is the penultimate precursor in the biosynthesis of cobalamin (vitamin B12) and is a powerful
antioxidant, serving as a superoxide dismutase and catalase mimetic and neutralizing nitric oxide and
peroxynitrite. We have found that administering cobinamide in the drinking water to mice with a fibrillin-1 mutation
analogous to a common mutation in Marfan patients abolished oxidative stress and pathological changes in the
aorta, and significantly reduced aortic dilation. Our goal is to develop cobinamide as a novel, disease-modifying
treatment that could be used in patients with MFS and other forms of aortic aneurysms associated with oxidative
stress. An international patent has been submitted for using cobinamide to treat aortic aneurysms, and Dr. Boss,
co-investigator on this application, holds patents for using cobinamide as an antidote against toxic chemicals.
In this Phase I SBIR grant, we propose to perform pharmacokinetic (PK) studies in rats after oral
administration of cobinamide (Aim I) and to synthesize sufficient non-GMP grade cobinamide for the PK studies
(Aim II). We propose four interrelated studies in Aim I. (A) Dose Determination Studies. We will determine the
single dose administered by gavage required to achieve the plasma concentration found after administering
cobinamide continuously in drinking water to mice. (B) Formulation Selection and Mode of Administration
Studies. We will compare four different cobinamide formulations, using the dose found in Aim 1A. We will
compare the PK profile between administering the drug by gavage to direct instillation into the duodenum in
cannulated rats, since gastric acidity could affect cobinamide absorption. The goal is to find the formulation and
administration mode that yield the highest plasma concentration for the longest time. (C) Bioavailability Studies.
We will use the optimal formulation and administration mode found in Aim 1B and compare the PK profile to that
found after injecting the drug intravenously. (D) Repeated Dose Studies. Using the formulation and
administration mode found best in Aim 1B, we will determine the frequency of administration required to maintain
a steady-state, target plasma concentration.
A subsequent Phase II SBIR grant would consist of synthesizing and formulating GMP-grade cobinamide,
and performing GLP-level PK and toxicology studies in rats and pigs. The SBIR studies would complement and
be performed simultaneously with efficacy and basic mechanistic studies supported by a five-year R01 grant
expected to start 04/01/22. Technical and business assistance is requested to develop a high-level plan
describing activities that would lead to FDA approval and commercialization of cobinamide.

Public health relevance
Aortic aneurysms in patients with Marfan Syndrome (MFS) can lead to sudden premature death. The vitamin B12 analog cobinamide reduces oxidative stress and prevents pathological changes in the aortas of mice with a genetic mutation analogous to a mutation in MFS patients; it, therefore, shows promise as a potential disease-modifying treatment for MFS and other forms of aortic aneurysm. In this Phase I grant, we will synthesize non-GMP grade cobinamide and perform pharmacokinetic studies after administering cobinamide orally to rats to determine the optimal dose, formulation, frequency, and mode of administration.